Metabolic vulnerability due to dysregulated lipid metabolism in PDAC cachexia

PROJECT SUMMARY
Cachexia is a devastating complication of cancers and other inflammatory conditions that is defined by rapid
and persistent loss of fat and muscle that is not reversed by caloric supplementation. Cachexia is a major
determinant of both lifespan and quality of life that compromises the ability of patients to recover from life-
saving or extending interventions. Although descriptions of cachexia go back as far as Hippocrates, the
mechanisms underlying this catabolic state are poorly understood, and there remain no effective treatments.
Over 80% of patients with pancreatic ductal adenocarcinoma (PDAC) suffer from cachexia at some point
during their cancer journey, adding significant morbidity and mortality to an already dire disease. We have
recently found that PDAC alters the ability of the body to utilize fat stores as fuels. The ability of an organism to
survive metabolic challenges, including low nutrition or infection, is dependent upon accessing energy stored in
fat and oxidizing it in the liver. In this proposal we will investigate the role of this altered lipid metabolism in
PDAC-associated cachexia and examine the relationship between adipose tissue, the liver, and skeletal
muscle preservation. The significance of this proposal resides in its use of genetic and metabolomic tools and
a unique patient tissue resource to investigate an unexplored area of the cancer macroenvironment with new
collaborations and efforts directed at isolating and defining the interorgan processes that enable resilience to
physiologic threats. The long-term goal of our research is to gain a mechanistic understanding of how lipid
metabolism impacts skeletal muscle homeostasis in normal physiology and how this is modified in cancer
cachexia in order to develop more effective therapeutic approaches.

Public health relevance
PROJECT NARRATIVE The majority of patients with pancreatic cancer suffer from involuntary weight loss, fatigue, and frailty, known as cachexia. These effects of cancer limit patients' quality of life, their ability to tolerate treatment, and can contribute to mortality. Our studies investigate how pancreatic cancer changes metabolism of fat stores to cause cachexia in the hopes of developing new effective treatments.